Administrative Core

Project Summary/Abstract
The UCSF Brain Tumor SPORE has three overall specific objectives: 1) to identify factors that contribute to the
likelihood of surviving brain cancer; 2) to identify noninvasive imaging parameters that can help predict
therapeutic response in patients with glioma; and 3) to develop better mechanism-based therapies for the
treatment of brain cancer. The Administrative Core of the UCSF Brain Tumor SPORE has been created to
supervise the activities of the UCSF Brain Tumor SPORE and to provide fiscal management, administrative
support, and the framework by which researchers can communicate and interact. The specific aims of the
SPORE Administrative Core are: 1) To evaluate research progress. The Administrative Core, through the
SPORE Executive Committee, the SPORE Steering Committee, and the SPORE EAB, will be responsible for
evaluating the progress of projects and making decisions regarding the continuation or replacement of
projects. 2) To provide fiscal management. The Administrative Core will distribute funds from the SPORE
Award, the Career Enhancement and Developmental Research Programs, SPORE Supplement Awards, and
discretionary funds provided by the institution. The Administrative Core will also be responsible for the timely
reporting of finances to Project Leaders and the SPORE PI/co-PIs. 3) To provide administrative support. The
Administrative Core will be responsible for the daily operations of the SPORE, for the preparation of SPORE-
related manuscripts, and for communications with NIH. 4) To facilitate communication between SPORE
investigators and between the SPORE and outside entities. The Administrative Core will be responsible for the
scheduling of all meetings, seminar series, and retreats, and for the distribution of the notices inviting
participation in the Career Enhancement Program and the Developmental Research Program. The
Administrative Core also facilitates communication with NIH and NIH-funded entities, and with the brain tumor
patient community. 5) To assist in compliance. The Administrative Core will be responsible for assuring
compliance and scientific integrity of all components of the SPORE. The Administrative Core will be used by
all Projects, Programs, and Cores in the SPORE.

Public health relevance
Project Narrative The UCSF Brain Tumor SPORE Administrative Core co-ordinates the planning, evaluation and administration of the UCSF Brain Tumor SPORE. The Administrative Core consists of a SPORE External Advisory Board, a SPORE Steering Committee, a SPORE Executive Committee, and the SPORE PI and co-PIs. The Administrative Core is linked to the governance structure of the UCSF Helen Diller Family Comprehensive Cancer Center and the PI is assisted by the SPORE Administrator.